Cytoskeletal mechanisms of dendrite arbor shape development

Abstract
The specification and dynamic modification of subtype specific dendritic architecture not only dictates how
distinct classes of neurons form functional connections with other neurons, but also directly influences subtype-
specific computational properties. Dendritic form, and by extension function, is chiefly mediated by subcellular
organization and dynamics of cytoskeletal components. Thus, identifying molecular factors and cellular
processes that regulate subtype specific dendritogenesis is essential to our understanding of the mechanistic
links between cytoskeletal organization and neuronal form and function in both health and neuropathologies.
Protein homeostasis, or proteostasis, is essential to cellular health and as a surveillance system against
neurotoxic aggregates implicated in numerous neurodegenerative disease states. Despite this importance,
relatively little is known regarding the normal developmental roles of proteostasis regulatory pathways in
driving dendritic diversity or subtype-specific cytoskeletal organization. Our work in the previous funding cycle
provided the foundations for combining neurogenetic manipulations, in vivo spatio-temporal multichannel
imaging and computational techniques for multichannel and time-varying neuronal reconstructions of subtype
specific dendritic cytoskeletal architectures. This strategy yielded novel insights into local cytoskeletal control
mechanisms regulating dendritic arbor diversity that could not have been solely predicted or quantitatively
characterized without the synergy of these approaches. For this next funding cycle, we hypothesize that the
evolutionarily conserved PP2A phosphatase and TRiC/CCT chaperonin complexes function as essential
proteostasis regulators that exert control over the spatiotemporal organization and dynamics of cytoskeletal
components underlying subtype-specific dendritic arbor diversity. To investigate this core hypothesis, we
propose the following tightly linked aims. First, we will elucidate the mechanistic role(s) of the PP2A
phosphatase and TRiC/CCT chaperonin complex in directing subtype specific dendritic arborization. Second,
we will identify the functional requirements and putative molecular targets of PP2A and TRiC/CCT in regulating
subtype specific dendritic cytoskeletal architecture and dynamics. Third, we will conduct computational studies
of dendritic morphology and spatio-temporal cytoskeletal distributions that directly integrates and synergizes
with the first two aims thereby generating a closed-loop investigational system. These studies will not only
reveal novel molecular mechanisms driving cytoskeletal organization and dynamics that functionally contribute
to the emergence of diverse dendritic arbors, but also develop and disseminate neuroinformatic tools and data
of broad impact to the neuroscience community.

Public health relevance
Project Narrative Understanding how diverse neurons acquire their specific structures is critical to revealing the foundations upon which a functional nervous system is built and modified in both normal healthy development and in the context of debilitating neurological diseases when this process is deranged. Mechanisms regulating protein activity and protein folding are essential not only to cellular health, but also as surveillance systems against potentially toxic protein aggregates that are known to contribute to numerous neurodegenerative diseases. By uncovering how protein regulatory pathways function in driving neural diversity, we develop important insights on nervous system functional integrity and potential routes for understanding and treating neurological disease when these pathways are disrupted.